CardioOnco-AI: AI-Empowered Cardiotoxicity Risk Prediction Among Breast Cancer Survivors Using Multi-Site Real-World Data

PROJECT SUMMARY
Advances in cancer prevention, diagnosis, and treatment have dramatically improved long-term survival of those
diagnosed with breast cancer. However, this success has been tempered by a parallel increased incidence of
adverse outcomes and chronic conditions in breast cancer survivors, including cardiotoxicity due at least in part
to cardiotoxic treatment regimens. Current evidence-based guidelines for preventing and controlling
cardiotoxicity in breast cancer survivors are broad, and we lack clear guidance for assessing individualized risks
of cardiovascular events. Existing cardiovascular disease (CVD) risk prediction models focus on the general
population and rely only on a limited number of variables. Thus, there is a critical need to develop novel AI-
powered informatics frameworks to build, maintain, and enhance models predicting cardiovascular risk among
breast cancer survivors across diverse health systems. Responding to the RFA-FD-25-015, the objective of this
application is to develop and validate a scalable, generalizable, and explainable AI-powered informatics
framework, CardioOnco-AI, which innovates on the curation and modeling of real world data (RWD) for
individualized prediction of cardiotoxicity among breast cancer survivors. Towards this objective, we propose the
following specific aims: 1) Data curation - extract and derive cancer phenotype and non-medical determinant of
health (nMDoH) variables to create research datasets for cardiotoxicity risk prediction through novel AI-
empowered informatics solutions; 2) EHR-based predictive modeling - develop and evaluate novel cardiotoxicity
prediction models for breast cancer survivors across two sites; and 3) Evaluation - assess the generalizability of
CardioOnco-AI in two large geographically diverse RWD consortia. This project will deliver a novel, generalizable
framework that integrates structured and unstructured RWD to improve cardiotoxicity risk prediction in breast
cancer survivors. This work directly aligns with FDA’s regulatory science priorities and supports safer post-
treatment survivorship care. The tools and methods developed will be adaptable to other sites, data
environments, and oncology drug safety surveillance efforts.

Public health relevance
PROJECT NARRATIVE We propose to develop innovative frameworks for accurate cardiovascular risk prediction in breast cancer survivors by leveraging electronic health record (EHR) data from both M Health Fairview and University of Texas, linked to public data sources, with the ultimate goal of improving monitoring and ultimately prevention of cancer treatment-associated cardiotoxicity.